Endothelial Injury and Repair: CardioPulmonary Vascular Biology COBRE

DESCRIPTION (provided by applicant): The overall objective of the Cardiopulmonary Vascular Biology COBRE is to bring together a group of investigators in the fields of pulmonary and cardiovascular diseases in a unique trans-disciplinary approach to improve understanding of the pathogenesis and treatment of vascular pathobiology in lung and heart diseases. The Specific Aims of this proposal are: l. Unite a group of multidisciplinary investigators in studies f vascular injury and repair in the pathogenesis of lung and heart injury. 2. Provide research support, protected time, and mentoring to enable junior investigators to attain independent research support in an incubator environment, coupled with a robust program for the nurturing of career development and attainment of additional research skills. 3. Identify and support pilot investigators who will be funded to obtain preliminary data for research grants. 4. Support junior and pilot investigators through mentoring and support from the Cores. 5. Establish the basis for multidisciplinary program project grant(s) for research in vascular injury and repair. We propose a Center that includes 5 junior investigators and 1-2 pilot investigators, supported by Administrative and Cell Isolation/Organ Function Cores. Junior and pilot investigators will be mentored by accomplished scientists with a strong focus on career development. A unique feature of the Cardiopulmonary Vascular Biology COBRE is the melding under a common theme of vascular biology of research done by collaborating MDs, PhDs, and MD/PhDs. An outstanding group of scientists on the External Advisory Committee will provide advice, oversight, and critique. The Center will be administered by the Ocean State Research Institute, a non-profit research and education foundation located at the Providence VA Medical Center. The junior investigators and mentors are faculty at Alpert Medical School of Brown University, and they are employed by the Providence VAMC, Rhode Island Hospital, or Brown University. Generous and sustained institutional support has been provided for this COBRE. This innovative and multidisciplinary Cardiopulmonary Vascular Biology COBRE will provide an environment that fosters creative and trans-disciplinary approaches to study of pathobiology of vascular components of lung and cardiovascular diseases. As the Center develops, the COBRE will be broadened to include other components of the vascular wall. By bringing together both basic and clinical scientists from cardiovascular and pulmonary backgrounds into a vascular biology center, this COBRE will enhance understanding of pathogenesis and treatment of vascular diseases and enhance research of these diseases, prevalent in RI.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cardiovascular and lung vascular diseases are important causes of morbidity and mortality in the US. A multidisciplinary group of MD, PhD, and MD/PhD investigators will develop a research center focusing on understanding the biology of vascular injury. Improved understanding of mechanisms of blood vessel injury promotes development of new and innovative treatments. This Vascular Biology COBRE will be first of its kind in Rhode Island, a state with a high burden of both heart and lung disease.